International Usher Syndrome Conference

Project Summary
Usher Syndrome (USH) is a devastating incurable syndrome resulting in deafness, vestibular dysfunction, and
retinal degeneration leading to blindness (retinitis pigmentosa). Usher Syndrome represents the most common
genetic cause of deaf blindness; it affects 20% of infants with bilateral moderate to profound congenital
sensorineural hearing loss, 15-30% of patients with retinitis pigmentosa and 50% of deaf-blind children. The
Usher gene family includes 12 genes encoding for proteins expressed in both the photoreceptor cells of the
retina and the sensory hair cells of the inner ear. Belonging to different families, the Usher proteins interact in a
network that appears to be essential for the proper development, maturation and survival of the photoreceptor
and inner ear hair cells.
This proposal is written to support the next International Symposium on Usher Syndrome. This conference will
be the fifth of its kind and is meant to convene scientists whose research and interest is closely related to Usher
Syndrome, and families and patients who suffer from the disease. It will take place in Nijmegen, Netherland,
June 19-21, 2025 and will include two scientific days and one family day. The goal of the symposium is to bring
together scientists, clinicians and Usher patients and their families in view of 1) promoting research in emerging
areas of Usher Syndrome with the goals of advancing diagnosis, prevention, treatment, and cure; 2) To present
new research findings and develop future research strategies among scientists involved in Usher Syndrome
research; (3) To promote and enhance collaboration among researchers and clinicians from different institutions
and different research focus areas who study Usher Syndrome. (4) To educate families affected by Usher
Syndrome about research advances and to promote collaboration between these families and Usher syndrome
researchers.
The Symposium will support the mission of the NIDCD and NEI by focusing on sharing new knowledge of a
syndrome that affects hearing, balance and vision and results in significant communication impairments. The
symposium will support the public health and educational mission of the NIH by including scientists, clinicians
and patients/families with USH to encourage collaboration on both a formal and informal basis.

Public health relevance
Project Narrative Usher Syndrome (USH) is an incurable syndrome that results in deafness, balance dysfunction, and blindness and is the most common cause of genetic deaf-blindness. We request support for the International Symposium on Usher Syndrome and 10th Annual USH Connection conference that will bring together scientists, clinicians and USH patients and families to: 1) Promote research in emerging areas of USH diagnosis, prevention, treatment, and cure; 2) Present new research findings and develop future research strategies; (3) Educate patients/families affected by USH about research advances and promote collaboration with USH researchers. Support is requested to offer scholarships for minority attendees and attendees with disabilities, provide access to those with disabilities, and defray the travel costs of some invited participants, as well as other costs associated with hosting the conference.